Organochlorine and Gene Expression of Sex Steroids in a Multigenerational Cohort

[unreadable] Description (provided by Applicant) [unreadable] [unreadable] [unreadable] [unreadable] [unreadable] [unreadable]